Immune cell skewing with RNA target site oligonucleotides to promote vascular smooth muscle cell homeostasis

Chronic allograft rejection remains a major obstacle to long-term success of solid organ transplantation despite
improvements in immunosuppression and advances in costimulation blockade. Following immune injury,
vascular smooth muscle cells (VSMCs) switch from a differentiated contractile to a synthetic phenotype and
proliferate, resulting in intimal expansion and vascular compromise, often causing ischemic organ failure.
Allograft-specific regulatory T cells (Treg) may inhibit immune cells without immunosuppression but their direct
effects on the pathologic VSMC phenotype switch have been insufficiently studied. Moreover, Treg heterogeneity
and plasticity associated with complex post-transcriptional regulation of gene expression by microRNAs
represent challenges for cellular therapies requiring expansion of Treg ex vivo. We hypothesize that mRNA-
specific enhancement of translation can skew the secretome of the alloantigen-specific Tregs toward promoting
VSMC homeostasis. This exploratory, developmental (R21) project will design and evaluate a novel approach
to promoting vascular smooth muscle cell homeostasis in the context of immune responses to vascular allografts
through modulation of the Treg secretome. In Aim 1, we will identify Treg-enriched secreted products promoting
VSMC homeostasis. We will expand alloantigen-specific Treg and identify clones that secret factors with
favorable effects on VSMC phenotype. Using two complementary secretome analyses (multianalyte
immunoassays from Isoplexis and pulsed SILAC followed by LC/MS-MS), we will select 2-3 Treg-enriched
factors for modulation. In Aim 2, we will design and evaluate locked nucleic acid (LNA)-modified mRNA target
site blockers (TSB) that specifically relieve miRNA-mediated translational repression and enhance production of
IL-10, as our model candidate, and newly identified Treg-enriched targets, to promote VSMC homeostasis. The
effects of the TSB on Treg and VSMC phenotype will be evaluated in vitro, followed by validation in 2 in vivo
models: (1) factor-enhancing effect on secondary lymphoid organ antigen-activated Treg, and (2) vascular-
stabilizing effect on minor antigen (HY) mismatch aortic allografts. The results of this exploratory study will newly
reveal specific regulatory networks of Treg-VSMC interactions and provide a proof of concept for a novel class
of therapeutics directed at improving long-term vascularized allograft outcomes.

Public health relevance
Chronic rejection of transplanted organs is the adverse outcome when graft blood vessels thicken, due to negative immune influences on the cells of the middle layer of arteries, smooth muscle cells (SMCs), which become dysregulated. This project focuses on defining which immune cell-produced factors have the greatest potential to promote healthy regulation of those SMCs, followed by enhancing their production through interference with influential regulatory small RNAs (microRNAs), to be tested in preclinical blood vessel transplant models. This would constitute a novel therapeutic approach to the maintenance of healthy organ transplants.